Feature selection of DNA methylation biosignatures for neuropathy with comorbid drug abuse in the setting of HIV infection

Distal sensory polyneuropathy (DSPN) remains the most common neurological complication in HIV-infected
population. Opiates and cocaine are often misused to manage neuropathic pain. These drugs, in turn, increase
the risk of DSPN and exacerbate DSPN severity. The interplay of DSPN and substance use disorder (SUD) is
associated with morbidity and mortality in HIV-infected individuals. Although neurotoxic effects of HIV-1 gp120
and antiretroviral medications contribute to DSPN through dysregulation of pro-inflammation genes, little is
known about the mechanisms of DSPN and DSPN with comorbid SUD. A major barrier to advancing our
understanding of DSPN is the inaccessibility of nerve tissues in living individuals and the absence of reliable
biomarkers to inform the diagnosis of DSPN in the setting of SUD and HIV infection. Our overarching goal is to
discover the DNA methylation signatures for DSPN, SUD, and their comorbidity. We focus on white blood cells
(WBCs) because of their role in orchestrating and effecting immune responses and because they are highly
accessible tissues. We hypothesize that DSPN emerges in the context of HIV infection as the result of HIV-1
enhanced expression of proinflammatory genes in many cell types, including WBCs. We also hypothesize that
DSPN emerges as the result of SUD-enhanced expression of proinflammatory genes in WBCs. Thus, DNA
methylation in WBCs is associated with DSPN that is influenced by SUD and contributes to HIV outcomes.
To test the hypotheses, we will select methylation features in WBCs for DSPN, SUD, and their comorbidity using
a combination of epigenome-wide association study (EWAS) and ensemble-based machine learning
approaches. Leveraging two well-established independent cohorts, we will first identify methylation sites in
WBCs for DSPN and SUD in four groups (DSPN+/SUD+, DSPN+/SUD-, DSPN-/SUD+, DSPN-/SUD-) in 2,000 HIV-
infected samples using a 2-stage EWAS followed by a meta-EWAS. We will then select methylation features
using machine learning methods and test the sensitivity and specificity to differentiate DSPN, SUD, and their
comorbidity. We will apply our in-house developed bioinformatic package, smartFeatureSelection. The
selected features will test associations with immune resilience (i.e. CD4+/CD8+) and HIV outcomes (i.e. frailty,
mortality). Finally, we will explore the biological functions of the identified methylation sites in postmortem human
brain and blood (N = 80) by RNA-seq and correlate methylation-regulated gene expression between WBCs and
neural cells. We expect to discover a set of biologically meaningful methylation features as a marker for HIV-
infected DSPN and SUD that can predict resilience and outcomes.
Employing a rigorous design and a powerful computational approach, this application proposes the first
epigenome-based prediction for DSPN, SUD, and their interaction. The identified features can serve as a
biomarker for this complex condition and have potential clinical use. The results will enhance the knowledge of
epigenetic mechanisms in blood and in brain for HIV-infected DSPN and SUD.

Public health relevance
Distal sensory polyneuropathy and substance use disorder are common in the HIV-infected population and can impact immune resilience and HIV outcomes. Applying a combination of epigenome-wide association and machine learning approaches, we aim to identify a panel of DNA methylation features in white blood cells for HIV-associated distal sensory polyneuropathy and substance misuse that link to immune resilience, HIV frailty and mortality. The selected features can serve as biomarker for neuropathy and enhance our understanding of the interplay between neuropathy and substance misuse in HIV-infected population.